Stanford Center for Clinical and Translational Research and Education

ABSTRACT
The mission of the Stanford CTSA is to transform clinical, translational, and science of translation
research and education (CTSRE) at Stanford and across the CTSA consortium. The Stanford CTSA’s
programs in CTSRE have been designed to extend from the earliest stages of the translational pipeline to the
“final mile” of implementation science at the patient and population level and to take full advantage of the rich
research and educational resources available at Stanford University. The overall goal is to make CTSRE more
effective and efficient to serve the health needs of more individuals and more diverse populations. During the
next seven years, the Stanford CTSA will achieve this goal by capitalizing on our greatest strengths, namely a)
training the next generation of clinical, translational, and science of translation researchers; b) developing and
implementing across all elements of our CTSA the principles of science of translation, including Rigor and
Reproducibility (SPORR); Team Science; Health Policy; and Research Equity, Accessibility, Diversity, and
Inclusiveness (READI); and c) innovating data driven and clinical operational approaches to accelerate, scale,
and diversify our translational research and science of translation research and educational efforts. We aim to
do this locally, regionally, and nationally in collaboration with our networks, including the CTSA consortium.
To that end, our first overarching aim is to educate and train the next generation of investigators who
make up the clinical and translational research “workforce” with the knowledge and skills in CTSRE to achieve
the vision of translational medicine in the 21st century and to meet the opportunities and challenges of
providing optimal, equitable healthcare delivery and access for all. Our second overarching aim is to a)
develop, optimize, and implement innovative data science and health informatics infrastructure, methods, and
tools to promote analysis of large-scale real world data to serve as the platform for the conduct of CTSRE,
accelerating the translation of discoveries into improved health outcomes; b) sustain, develop, enhance, and
implement infrastructure, methods, services, and tools to support our entire CTSRE workforce locally and
across the CTSA Hub; c) imbue all Elements of our Stanford CTSA with science of translation principles,
including rigor and reproducibility (SPORR), team science, health policy, and Research Equity, Accessibility,
Diversity and Inclusiveness (READI) in support of our CTSRE mission. Our third overarching aim is to
maximize community engagement, team science, and diverse and inclusive approaches so our CTSRE
products benefit all segments of the population. Finally, we aim to develop and employ innovative state-of-the-
field evaluative approaches to determine the effectiveness of all our CTSRE efforts. With Stanford CTSA’s
record of accomplishments to date, supportive institutional environment, well-developed infrastructure,
integrated leadership, and expanding network of collaborators and community partners, we are well-positioned
to execute on our vision for the next seven years.

Public health relevance
PROJECT NARRATIVE The overall vision of Stanford’s CTSA-supported research “Hub” is to transform clinical, translational, and science of translation research and education (CTSRE), by making CTSRE more effective and efficient at discovery, clinical, translational, and science of translation research and education to serve the health needs of diverse individuals. In the next seven years, we believe the Stanford CTSA can best achieve this vision by capitalizing on our greatest strengths, namely a) educating and training the next generation of clinical, translational, and science of translation researchers; b) developing and implementing across all elements of our CTSA the principles of the science of translation, including rigor and reproducibility (SPORR), team science, health policy, and Research Equity, Accessibility, Diversity, and Inclusiveness (READI); and c) developing and implementing innovative, data driven, and clinical operational approaches to accelerate, scale, and diversify our translational research and science of translation efforts. We aim to employ state-of-the-field evaluative approaches to determine the effectiveness and maximize the impact of our Stanford CTSA CTSRE efforts locally, regionally, nationally, and across our networks, including the CTSA consortium.